BLR&D Research Career Scientist Award Application

For over a decade and a half, Dr. Dracheva, the Principal Investigator (PI), has strategically centered her work
on uncovering the molecular underpinnings of central nervous system (CNS) disorders common among U.S.
military Veterans. These encompass psychiatric and neurological disorders, such as major depression disorder
(MDD) and suicide, schizophrenia (SZ), opioid addiction, as well as amyotrophic lateral sclerosis (ALS) and
spinal cord injury. The existing treatments for these disorders are extremely limited and often ineffective for a
large subset of patients, hence there is a strong need to advance our understanding of their biological basis to
develop novel more efficacious medications. The essence of the PI’s approach lies in deciphering how genetic
and epigenetic mechanisms orchestrate gene expression in the healthy brain and identifying malfunctions
leading to disorders. Her multidisciplinary research integrates insights from genetics, epigenetics, molecular
biology, neural development, and evolution.
The PI’s research has made significant contributions to the field, both conceptually and
methodologically. For example, her studies identified unique molecular markers associated with suicide, that
are distinct from those related to underlying psychiatric conditions, e.g., MDD or bipolar disorders. She also
discovered a unique human component to vulnerability towards opioid addiction, highlighting the limitations of
animal models and underscoring the necessity of studying opioid addiction in the human brain, as practiced in
her laboratory. These findings are particularly relevant to U.S. Veterans, who exhibit significantly higher rates of
suicide and opioid overdose mortality compared to civilians. Methodologically, her lab champions cell-type-
specific experimental methods, considering the brain's cellular diversity. This innovative strategy deepens our
understanding of disease mechanisms and the complexities of brain disorders. The PI’s pioneering methods
and insights have been adopted by numerous laboratories, leading to high-impact collaborative research.
In this application, the PI seeks a VA BLR&D Research Career Scientist (RCS) Award based on her
important contributions to research, collaborations, training, editorial work, and administration, both inside and
outside the VA. Her accomplishments are evident from a steady stream of publications in reputable journals,
grant awards (VA Merit and NIH grants), mentorships, membership in editorial boards (Science Reports,
Frontiers in Pharmocol, and Frontiers in Neuroscience), ad hoc reviewer’s assignments for numerous journals,
intramural committee appointments at her VA, and extramural work as a grant reviewer for VA, NIH, and
foundations. Dr. Dracheva is a founding member of the PsychEncode Consortium that generates large scale
transcriptional and epigenetic data on tissues and cells from healthy and diseased human postmortem brains,
including from patients with post-traumatic stress disorder (PTSD), MDD, and SZ, which are highly prevalent in
U.S. Veterans. These data are shared with the scientific community to accelerate the discoveries on the
molecular pathophysiology of these disorders.
Impact: To the best of our knowledge, the PI’s current VA Merit grants are the first studies to elucidate the role
of microglia in pathophysiology of MDD and to identify brain cell-type-specific markers associated with a slower
progression of ALS. Her future research efforts in the VA include investigating the molecular basis of opioid
addiction at a single cell level and dysregulation of DNA hydroxymethylation in the brain of suicide victims. The
RCS Award will enable PI to broaden her research scope and establish new collaborations. These research
efforts will significantly enhance our comprehension of the neurobiology of brain disorders, and more
importantly, pave the way for the discovery of innovative therapeutic targets, thereby addressing the prevailing
brain disorders among Veterans with greater efficacy.

Public health relevance
For over a decade, Dr. Stella Dracheva's research has focused on deciphering the molecular underpinnings of brain disorders prevalent among U.S. military Veterans. Her work encompasses psychiatric and neurological disorders such as major depressive disorder, suicide, schizophrenia, opioid addiction, as well as amyotrophic lateral sclerosis and spinal cord injury. Current treatments for these conditions are limited and often ineffective for many patients, underlining the urgent need for a deeper biological understanding to facilitate novel therapeutic development. Dr. Dracheva's track record of federal funding and impactful publications in high-ranking journals demonstrate her substantial contributions to these research areas. The RCS Award will enhance Dr. Dracheva's VA research, fostering new investigations, collaborations, and mentorship opportunities.